Translational Science Laboratory Shared Resource

TRANSLATIONAL SCIENCE LABORATORY (TSL) SHARED RESOURCE: SUMMARY
The Hollings Cancer Center (HCC) Translational Science Laboratory (TSL), a new shared resource as of 2017,
works closely with clinical, translational, and basic scientists to drive the development and use of novel
biomarker assays to provide the most innovative discovery, pre-clinical and correlative science studies. The
mission of TSL is to facilitate the translation of basic science research to the clinical setting and vice versa to
improve diagnosis and treatment strategies for cancer patients. Moreover, TSL provides expertise in drug
development and helps basic and translational scientists explore pre-clinical hypotheses and conceive and
execute strategic, correlative science plans for clinical trials at HCC. Specifically, TSL aims to: 1) provide high-
quality molecular services, providing timely NGS-based library preparation dependably and cost-effectively; 2)
perform consulting on high-dimensional transcriptomic and protein profiling analyses, the design and execution
of single-cell/nuclei sequencing, bulk NGS, NanoString nCounter analysis, spatial transcript/protein profiling
experiments, and quantitative multiplex immunofluorescence; and 3) offer method development, training, and
education. Directed by Martin J. Romeo, PhD (DCT), and staffed by four technical experts, this facility
provides extensive molecular genomics/transcriptomics and histology/IHC/multiplex immunofluorescence
capabilities, an active educational platform, and the development of new methodologies, plus assists in data
analysis and interpretation for publication. Services offered through TSL include: consultation, training,
education, data analyses, preparation of data for publication, and a full suite of molecular services, including
automated nucleic acid (RNA, DNA, miRNA) extraction from various sources (whole blood, tissue, cells, FFPE
tissue), nucleic acid quantification and QC, DNA shearing, droplet digital PCR (ddPCR), next-generation
sequencing library preparation (bulk RNAseq, ChIPseq, whole genome methylation-seq, ATACseq,
miRNAseq, targeted capture), single-cell/single-nuclei RNAseq and Multiome (single-nuclei
RNAseq+ATACseq), NanoString bulk targeted transcriptomic analysis and GeoMx digital spatial profiling of
both protein and RNA. The ability to provide high-dimensional RNA and protein analysis at the single-cell level
has proven to be a powerful discovery tool. Forty-seven (47) HCC members used TSL during the current cycle,
providing key data contributing to four successful NCI-funded grant applications and 16 peer-reviewed
publications in high-impact journals, including Sci Immunol, Cell Reports, Cell Reports Med, Cell Death and
Differ and Nat Commun. In summary, the TSL Shared Resource advances, supports, and provides critical
emerging molecular and spatial research tools and methodologies to the HCC community.